Understand the function of the MOS4-associated complex in microRNA biogenesis

Project Summary
Multicellular organisms encode small non-coding RNAs called microRNAs (miRNAs) to regulate gene
expression by exerting repression on their target mRNAs. Defective synthesis of miRNAs and abnormal
miRNA activity are associated with developmental defects and diseases, including human. Thus, miRNAs are
being targeted or used for both diagnostic and therapeutic purposes. However, there are several critical caps
in miRNA biogenesis. Our long-term goal is to elucidate how miRNA levels are precisely controlled.
miRNAs are derived from the primary miRNA transcripts (pri-miRNAs), which contain one or more
imperfect stem-loop (s) where miRNAs reside. Pri-miRNAs are co-transcriptionally processed. However, it is
not clear how the processing complex is formed and recruited to pri-miRNAs. Moreover, most pri-miRNAs are
non-coding RNAs, and therefore, are likely targets of the nuclear RNA quality control machinery (QC). Indeed,
failure to protect pri-miRNA from degradation causes development defects. However, the process protecting
pri-miRNA from degradation is not defined.
The MOS4-assoicated complex (MAC) from plants is a conserved complex composed of core and
accessory components. The ortholog complexes of MAC in metazoan and fungi are known as the PRP19
complex and the nineteen complex, respectively. They associate with spliceosome and are required for
splicing, DNA damage repair and genome stability. Our previous study leads us to propose that MAC links pri-
miRNA transcription, processing and stability together. We hypothesize is that MAC is important for co-
transcriptional processing and stability of pri-miRNAs. Our specific aims will test the following hypotheses: 1)
MAC functions as a whole complex to modulate miRNA biogenesis; 2) MAC binds pri-miRNAs to protect them
from XRN2/3 activity; 3) Phosphorylation-dependent ubiquitin ligase activity of MAC3 is critical for miRNA
biogenesis.
Collectively, our research will produce a broad impact by characterizing the roles of MAC in the
transcription of pri-miRNAs, formation of processing complex, stabilization of pri-miRNAs and regulation of the
activity of processing complex. Consequently, our research will improve our ability to understand the miRNA-
mediated gene regulation and to develop miRNA-related technologies that can be used to improve human
health and agricultural trait of crops

Public health relevance
PROJECT NARRATIVE MicroRNA (miRNA) are important regulator of gene expression and have been targeted or used for both diagnostic and therapeutic purposes. Our proposed research aims to understand the mechanisms by which a conserved MOS4-associated complex (MAC) regulates miRNA biogenesis. Consequently, our research will improve our ability to understand the miRNA-mediated gene regulation and to develop miRNA-related technologies that can be used to improve human health and agricultural trait of crops.